Administrative Core

PROJECT ABSTRACT
The Kansas INBRE (K-INBRE) network proposes an Administrative Core to oversee the operations of
the K-INBRE program. The long-range objective for the Administrative Core is to provide leadership, oversight,
financial and reporting duties, and manage the evaluation components of the K-INBRE program. In addition, this
Administrative Core houses two critical components of the K-INBRE program: oversight and decision-making of
the funding selections (Incentives & Awards Committee) and oversight, tracking, and scholarship associated with
undergraduate research opportunities (Student Research Program). Our purposes are to provide professional
oversight to maintain this long-standing and highly functional IDeA program and to expand and integrate with
existing educational and training programs operating the K-INBRE Network. The Administrative Core will function
through the following 3 Aims: 1) provide administrative oversight to the overall K-INBRE program, 2) provide
oversight and assistance to the two working committees in the Administrative Core, and 3) leverage K-INBRE
resources to integrate with existing Kansas programs and increase research support through administrative
supplements.
A strength of the K-INBRE Administrative Core is the longstanding continuity and success of the
experienced leadership and administrative personnel. The primary functions of the Administrative Core continue
to adjust to meet all compliance requirements for NIH. The Incentives & Awards Committee oversees decisions
on funding and supervision of all awards within the K-INBRE. The Student Research Program supports
biomedical research experiences for undergraduates on K-INBRE network campuses. This Student Research
Program will oversee programs directed by the 9 Campus Coordinators to attract and retain promising students
into biomedically-related science majors and involve these students in cutting-edge research, assist in the
implementation of student-focused symposia and workshops, and supervise the award of funds to support in
unique undergraduate training opportunities. An innovation for the current iteration of the K-INBRE is a new
funding mechanism to increase support to primarily undergraduate institutions (PUIs) for undergraduate research
participation in the classroom (CURE Awards). These new features will augment the success of these Kansas
programs and increase participation for our vast number of K-INBRE faculty participants and laboratories.